Nanoscale Coordination Polymers Co-deliver Chemotherapeutics and siRNAs for Efficacious Treatment of Resistant Ovarian Cancer

Project Summary:
Ovarian cancer (OCa) is the fifth leading cause of cancer death for women in the United States. Intrinsically
resistant and recurring ovarian cancers are a terminal disease that cannot be cured with existing therapeutics.
Considering the molecular and genetic heterogeneity of tumors, we hypothesize that efficacious OCa therapy
can be developed by determining the genetic abnormalities found in tumors of individual OCa patients and
designing personalized therapy that can overcome patient-specific multi-drug resistance (MDR). We propose to
develop robust nanoscale coordination polymers (NCPs) for the co-delivery of front-line and second-line OCa
chemotherapeutics (cisplatin or cisplatin plus gemcitabine) and siRNA cocktails targeting MDR genes. A unique
endosomal escape mechanism will be elucidated and is expected to be generally applicable to the rational design
of nanocarriers for efficient delivery of biologics in vivo. This project will not only provide new fundamental insights
nanomedicine research, but also holds great promise for clinical translation for the personalized treatment of
resistant OCa.
Aim 1: Develop NCP/siRNAs and evaluate their in vitro effects on resistant OCa cell lines. Two NCP/siRNAs
formulations with chemotherapeutics in the core and siRNAs targeting MDR in the shell will be developed and
characterized. The in vitro gene silencing and cytotoxicity will be evaluated in resistant OCa cells.
Aim 2: Evaluate the anticancer efficacy of NCP/siRNAs in orthotopic mouse tumor models of resistant OCa. The
general toxicity and anticancer efficacy of NCP/siRNAs will be assessed in mouse models.
Aim 3: Actively target NCP/siRNAs by incorporating Her2/neu antibody fragments into the NCP/siRNAs shell.
Small protein Her2/neu antibody fragments will be conjugated to a lipid and incorporated into the outer shell of
NCP/siRNAs and the resulting nanoparticles will be tested in Her2/neu high expressing and Her2/neu low
expressing resistant OCa tumor models to evaluate changes in pharmacokinetics, tumor deposition, and efficacy.
Aim 4: Evaluate the anticancer efficacy of NCP/siRNAs and NCP/siRNAs/H2A in patient-derived xenograft (PDX)
mouse models of resistant OCa. The expression of MDR-associated genes will be analyzed in OCa tumor PDX
samples collected by the Mayo clinic. Personalized therapy will be designed entailing chemotherapeutic agent(s)
and the choice of siRNAs targeting MDR genes. Confirmed platinum-resistant tumor cells will be used to evaluate
the anticancer efficacy of NCP/siRNAs in orthotopic PDX OCa mouse models. Tumors from Her-2/neu receptor
positive and negative patients will be further evaluated for anticancer efficacy by NCP/siRNAs/H2A.
Through these aims we seek to establish a new paradigm for the treatment of resistant OCa. NCP/siRNAs
can provide personalized therapy for OCa patients and achieve greatly enhanced anticancer efficacy in resistant
OCa. As the standards of care for cervical and other cancers, cisplatin-based NCP/siRNAs can have broad
impact on treating other resistant cancers.

Public health relevance
Project Narrative Resistant ovarian cancers are a terminal disease that cannot be cured with existing therapeutics. We propose to develop robust nanoscale coordination polymers (NCPs) for the co-delivery of chemotherapeutic agents (cisplatin or cisplatin plus gemcitabine) and small interfering RNA (siRNA) cocktails targeting multi-drug resistance (MDR) pathways. By identifying three MDR genes with the highest expression levels in patients' tumors, NCPs carrying chemotherapeutic agents and siRNAs targeting these genes will be designed as personalized therapies for treating these patients with resistant OCa.